Mechanisms of replication fork protection and recovery

Summary
During this funding period, we uncovered that the ATR signaling pathway is essential for safeguarding single-
stranded (ss)-DNA gaps from being degraded by nucleases, as well as facilitating their effective repair when
cancer cells undergo transient treatment with PARP inhibitors (PARPi). Moreover, we found that ssDNA gaps
fail to be repaired in conditions where PARPi treatment is continuous, leading to their collision with DNA
replication forks and the subsequent breaking of these forks. These broken forks are irreparable in cancer cells
lacking the function of the breast cancer susceptibility genes BRCA1 and BRCA2. However, they are repaired
by BRCA-proficient cells, indicating the presence of a fork recovery pathway that is absent in BRCA-deficient
cells and whose absence contributes to the susceptibility of BRCA mutant cancers to PARPi.
Based on these findings, we propose that the ATR signaling pathway has a previously underrecognized function
in controlling the processing and repair of ssDNA gaps in cells treated with PARPi. The first aim will define the
actual mechanisms by which ATR signaling limits the resection of ssDNA gaps by nucleases, as well as the
mechanisms by which ATR signaling promotes the repair of gaps in cancer cells exposed to PARPi. We will
achieve this goal by coupling our single-molecule DNA fiber assays with GAP-iPOND, a modified iPOND assay
that we specifically developed to unbiasedly identify proteins associating with gaps in an ATR-regulated manner.
Moreover, the electron microscopy approach available in Vindigni lab to directly visualize and measure the size
of the ssDNA gaps on DNA replication forks provides a unique tool to study the formation, processing, and repair
of ssDNA gaps. Using the same techniques, the second aim will test the innovative hypothesis that ATR, together
with key recombination factors RAD51, BRCA1, and BRCA2, is also required to promote the repair of broken
forks originating from ssDNA gap-replication fork collisions under conditions of continuous PARPi treatment. As
tumors are exposed to PARPi repeatedly during cancer treatment, the abilities of tumor cells to repair both
ssDNA gaps and broken forks are likely relavent to the therapeutic response to PARPi. Our studies will establish
a new paradigm for the roles of the ATR signaling pathway and central recombination factors in the processing
and repair of ssDNA gaps and broken forks in PARPi-treated cancer cells. They will also reveal how these
pathways are deregulated in BRCA-deficient tumors and how their deregulation contributes to PARPi sensitivity.
Interestingly, we also found that PARPi-resistant cells have fewer ssDNA gaps and DNA breaks compared to
the PARPi-sensitive counterparts, and that inhibiting ATR activity restores ssDNA gap degradation and PARPi
sensitivity. Thus, Aim 3 will test whether the pathways of ssDNA gap protection and fork repair are rewired in
BRCA1-mutant cells when they become PARPi resistant. This knowledge is essential for a better understanding
of the molecular mechanisms that dictate PARPi response in BRCA-deficient tumors and for developing new
molecularly guided strategies to overcome PARPi resistance.

Public health relevance
Project Narrative Single-stranded (ss)-DNA gaps are genome-destabilizing structures that require prompt repair to prevent DNA breakage and genome instability. We will investigate the mechanisms by which the ATR signaling pathway, along with central recombination factors, regulate the processing and repair of ssDNA gaps in cancer cells treated with PARP inhibitors and reveal how these pathways are deregulated in BRCA-deficient tumors. This is critical to explain why ssDNA gaps cannot be properly repaired in BRCA-deficient cells and to better understand the molecular mechanisms that dictate PARPi response in BRCA-deficient tumors, providing a mechanistic basis for improved therapies.